Vascular Biology 2023 - Annual Meeting of the North American Vascular Biology Organization

Vascular Biology 2023
Annual Meeting of the North American Vascular Biology Organization
Organizers: Andreas Beyer* (Medical College of Wisconsin), Erika Boerman* (University of Missouri), Jason
Fish (University of Toronto), Gabrielle Fredman (Albany Medical Center), Guillermo Garcia-Cardena (Brigham
& Women's Hospital/Harvard Medical School), Miranda Good* (Tufts University School of Medicine), Mark
Majesky (University of Washington), Stefania Nicoli (Yale School of Medicine), A. Wayne Orr (Louisiana State
University, Health Science Center – Shreveport), Kristy Red-Horse (Stanford University), Arndt Siekmann
(University of Pennsylvania), and Ying Zheng (University of Washington)
October 15-19, 2023
Newport Harbor Island Resort, Newport, Rhode Island
Principal Investigator: Ying Zheng
Project Summary/Abstract
The vascular biology field is undergoing a transformation as new technological developments and discoveries
are revealing the extent and mechanisms of vascular diversity. Vascular biologists have a growing appreciation
for how vessel structure and function can vary in different organs, developmental stages, and disease contexts
and how this variation can impact therapeutic strategies for tackling a wide range of pathologies. Two
important factors that contribute to vascular diversity are (1) the genetic patterning of developing vessels, and
(2) the surrounding environment in which vessels grow and adapt. Vascular Biology 2023 (VB2023) will
provide a forum for in-depth exploration of these factors by covering the themes of (1) development and
genetics, (2) matrix biology and bioengineering, (3) signaling and (4) inflammation. The combination of these
four themes fosters exciting opportunities for vascular biologists with diverse expertise to collaborate and make
discoveries. In addition, VB2023 will host the Microcirculatory Society (MCS) as its guest. The MCS brings
classical expertise in microcirculatory physiology and function, and benefits the molecular, genetic, and
bioengineering approaches of NAVBO meeting participants, and vice versa. Overall, VB2023 aims to bring
together scientists focused on developmental, genetic, matrix, bioengineering, signaling, inflammation and
microcirculatory aspects of the vasculature so that their cross-fertilization can progress the field's
understanding of vascular development, diversity, and therapeutic potential.
VB2023 will be an international meeting that draws researchers from academia, industry, and government and
that incorporates both trainees and established scientists. The meeting will be held at Newport Harbor Island
Resort, from October 15-19, 2023. The roster of organizers and of invited speakers provides a diverse and
inclusive face to the meeting, with women, junior faculty, and individuals from underrepresented groups
featured. In addition, a larger number of speakers will be selected from abstract submissions than at past
versions of this meeting to give trainees and junior faculty additional opportunities to present their research and
to promote diverse voices. The meeting will include 18 concurrent sessions across the four main topics and
two cross-over themes on imaging and translational science. Keynote, NAVBO and MCS award lectures and
the final session on Plasticity in the Vasculature are general sessions that will unify all meeting participants in
one room. Additional opportunities for formal and informal interactions will occur at poster sessions, group
meals, nano-talks, and a conference-wide reception on opening night. Altogether, VB2023 will serve as a
nexus for scientists of diverse career stages, backgrounds, and perspectives to come together for four days of
intensive discussion and interaction that will foster new ideas and collaborations to advance the field of
vascular biology and will highlight potential areas of therapeutic opportunities to promote the NHLBI mission.

Public health relevance
Vascular Biology 2023 Annual Meeting of the North American Vascular Biology Organization with guest society: Microcirculatory Society October 15-19, 2023 Newport Harbor Island Resort, Newport, Rhode Island Principal Investigator: Ying Zheng Project Narrative: At this vascular biology meeting, scientists will present new discoveries in developmental vascular biology, microcirculation, matrix biology, bioengineering, vascular genetics, vascular signaling, and inflammation and will openly discuss the impact of their findings on vascular development, health, and disease. The integrated topics and participation by the Microcirculatory Society will facilitate interactions between senior researchers and trainees with overarching common interests, who might otherwise not have opportunities for direct interaction and scientific exchange. Moreover, the conference will provide a forum for dialogue between basic and clinical/translational researchers, thereby stimulating discussions and innovations about how to optimize therapeutic approaches for the treatment of vascular pathologies.